Administrative Core

CORE A: ADMINISTRATIVE CORE
Abstract
The administrative core of this Program Project grant seeks to centralize purchasing, progress reporting,
financial reporting and communication with NIAID. The administrative core also aims to coordinate weekly lab
meetings between Project group labs, monthly lab meetings between Project leaders, biannual meetings of the
Internal Advisory Board and annual meetings of the External Advisory Boards. Lastly, the administrative core
will coordinate travel arrangements for 2-4 seminar speakers a year and travel arrangements for the External
Advisory Board. This will be accomplished through existing infrastructure within the Department of Pathology at
Case Western Reserve University School of Medicine and under the direction of Drs. George Dubyak and Dr.
Derek Abbott.

Public health relevance
CORE A: PROJECT NARRATIVE This activity serves to organize interproject communication and management and as the interface between the Program Project and the NIAID. This activity also coordinates the External Advisory Board, the Internal Advisory Board and invited Seminar Speakers.